BIOLOGICAL TESTING FACILITY - ADMINISTRATIVE / MANAGEMENT / DATABASE TASK ORDER

The National Institute of Child Health and Human Development (NICHD) has a mission
to develop safe and effective contraceptives for both men and women. The Biological
Testing Facility for CDP has the scope and objective of conducting preclinical
development activities associated with development of new products for contraception in
men and women. The activities covered by this task are critical to the CDP program and
cannot be interrupted.